ACTG 273: HIVIG IN SLOWING DISEASE PROGRESSION IN HIV INFECTED CHILD

The study is based on the hypothesis that HIVIG will decrease viral burdens in children with moderately advanced HIV infection. Its primary objectives include evaluating HIVIG's (a) safety & tolerance; (b) dosage & pharmacokinetics by serial measurements of immunoglobulins, anti-p24 antibody & rubella antibody titers, and (c) anti-viral activity at 3 dosage levels by assays of viral burden. Its secondary goal will be to collect lab & clinical data by monitoring growth/weight, CD4 counts, incidence of opportun. infections, & survival rates.